MECHANISM OF GLUCOSE INTOLERANCE IN PREADOLESCENT/ADOLESCENT CHILDREN WITH IDDM

The euglycemic, hyperinsulinemic and hyperglyemic clamp techniques are being employed to determine the effects of age and development stage on insulin sensitivity and insulin secretion in childhood health and disease. Currently, the hyperglycemic clamp and oral glucose is being utilized to assess efffects of gut factors on insulin responses to glucose.